Probing Molecular Mechanisms of Allosteric Inhibition of HIV-1 Reverse Transcriptase

Project Summary/Abstract
HIV remains a major global health issue; strict adherence to combined antiretroviral therapy can reduce
a patient's active virus to undetectable levels, but the presence of latent viral reservoirs necessitates lifelong
adherence to antiretrovirals. HIV-1 reverse transcriptase (RT) is a major target in the treatment of HIV as it is
responsible for producing a double stranded DNA copy of the viral genome, which can be integrated into the
host. RT inhibitors fall into two major classes: nucleoside RT inhibitors (NRTIs) which are incorporated into the
growing DNA chain but usually lack the 3' hydroxyl group needed to continue reverse transcription, and non-
nucleoside RT inhibitors (NNRTIs) which bind to an allosteric pocket 10Å away from the active site, causing a
conformational change which alters the rate of chemical catalysis. These two classes of inhibitors are typically
combined when treating patients to provide more protection against inevitable drug-resistant mutants. In cells,
NNRTIs have shown synergy with NRTIs, but some in vitro experiments suggest that NRTI incorporation and
NNRTI binding are mutually exclusive. The molecular mechanism which underlies these drug interactions
remains unclear. Additionally, recent studies have revealed that a subset of NNRTIs can enhance RT
homodimerization and induce HIV-specific pyroptosis by prematurely activating the viral protease. This subset
of compounds may be promising components of new “shock and kill” therapies, which aim to cure HIV by
activating viral reservoirs and killing HIV-infected cells. While these dual function NNRTIs would represent an
exciting advancement in HIV treatment, the mechanistic and structural features of this process are not yet
understood. The proposed project will provide insights into the allosteric interactions underlying these
two key processes using complementary kinetic, structural, and dynamic methodologies. In Aim 1, I will
investigate the mechanism for crosstalk between the active site and the NNRTI-binding site. To do this, I will
use transient kinetic analyses to determine whether incoming nucleotides can be incorporated in the presence
of a covalent NNRTI, which cannot be displaced. Additionally, I will identify long-range interactions responsible
for allosteric inhibition with HDX MS experiments. In Aim 2, I will identify key structural characteristics of
dimerizing NNRTIs and the underlying mechanism by which they mediate this dimerization effect. To do this, I
will use complementary X-ray crystallography and cryoEM techniques to determine the structures of NNRTIs
bound to the p66/p66 homodimer and p66 monomer and identify the interactions between dimerizing NNRTIs
and their binding site(s) which are responsible for this effect. I will also monitor the progression from p66
monomer to p66 homodimer in the presence of dimerizing NNRTIs by HDX MS to determine the mechanism
by which they enhance dimerization. The insights gleaned from the proposed experiments will lay the
foundation for the development of novel NNRTIs which have better synergy with NRTIs and are more potent
enhancers of RT homodimerization.

Public health relevance
Project Narrative Non-nucleoside inhibitors of HIV reverse transcriptase (RT) remain successful components of combined antiretroviral therapy regimens and have newly discovered HIV-specific cell killing activity, which makes them potential components of future HIV cure strategies. The aim of this proposal is to examine the allosteric networks which allow these inhibitors to block viral replication by inhibiting nucleotide incorporation and kill HIV-infected cells by enhancing RT homodimerization. This work provides the foundation for the development of novel inhibitors which take better advantage of synergy with nucleoside inhibitors and have more potent cell killing activity.